NICHD HUMAN BIOSPECIMEN REPOSITORY

NICHD conducts various studies focusing on child health and human development and as such has generated and will continue to generate collections of biospecimens pertaining to these research activities. The biospecimens range from neonatal to later childhood samples and those from pregnancy. NICHD seeks to establish a specimen storage service that will provide a state-of-the-art inventory system coupled with storage and disbursement of these biological specimens collected for NICHD intramural and extramural research initiatives.